Early in vivo Expressed Antigens and their Role in Virulence, Immune Response, and Vaccines for Coccidioidomycosis

OVERALL Section
Title: Early in vivo expressed antigens and their role in virulence, immune response, and vaccines for
coccidioidomycosis.
SUMMARY
Coccidioidomycosis, also known as Valley Fever (VF), is an important fungal disease caused by two different
Coccidioides species that results in regionally important mortality and even greater morbidity. We have
assembled a team to define the changes that occur in human and animal immune responses to VF, and to use
this knowledge for designing new vaccines and diagnostic tests. This work will capitalize upon our detailed
observations of Coccidioides gene expression patterns during the earliest stages of infections. We hypothesize
that some Coccidioides early genes are virulence factors and critical for causing disease. Research Project 1
will test their role through gene knockouts using CRISPR-Cas9 technology and virulence testing in wax worm
(Galleria) and mouse VF models. Critical virulence factors will become diagnostic and vaccine targets. In addition
to the wax worm and mouse models, we develop a non-human primate (pig-tailed macaques) that will more
closely resemble VF in humans. In humans and vertebrate animal models, the role of T cells cannot be
overemphasized and Research Project 2 will use focused deep DNA sequencing to identify classes of T cell
receptors (TCR) that develop in response to early expressed Coccidioides genes. We will generate TCR
sequences from patients at three clinical locations that span the endemic zones for the pathogen. The TCR
repertoire from patients will be used to identify novel diagnostic signatures (e.g., public TCRs) and, also, help
identify immune responses to key antigens that can be targeted for vaccine development. Hence, both TCR and
early virulence genes represent excellent candidates for vaccine design that will be explored in Research
Project 3 using nucleic acid (NA) based vaccines (RNA and DNA) that can rapidly test a large panel of antigens
through the immunization of mice against infection. The DNA vaccine will be based upon delivery on gold
nanoparticles and Gene Gun, while the mRNA employs self-replicating RNA molecules (repRNA) and a Lipid
InOrganic Nanoparticle (LION). Both are proven technologies that are moving forward into clinical trials for other
diseases. Our goal in the NA vaccine mouse studies is to identify the best antigens and delivery modality for
vaccine testing in the NHP model and to define their immune mechanisms of protection. This work is only
possible through the integrated efforts of investigators at seven different institutions, including three clinical sites,
as no single institution has the requisite breadth of expertise and infrastructure. While we will generate
fundamental knowledge about Coccidioides and VF, we will also make translational advances towards
preventing and diagnosing the disease.

Public health relevance
NARRATIVE Valley Fever is a fungal disease that causes mortality and morbidity across a large range of the western United States. Our work will lead to a better understanding of the fungal infective process, which will help in the development of prevention, therapeutic, and diagnostic strategies. Our ultimate goal is the development of a highly efficacious nucleic acid vaccine to provide protection against Valley Fever.